Understanding the effects of a family preservation program for parents with intellectual disability

PROJECT SUMMARY
Children of parents with intellectual disabilities (ID) are disproportionately represented in child welfare
settings. They experience higher rates of foster care placement and termination of parental rights compared
to children of parents without ID. Despite research documenting negative trajectories and outcomes for
children of parents with ID, there is limited research focused on child welfare interventions that are effective in
preventing child maltreatment in this population. Our long-term goal is to identify effective interventions to
reduce child maltreatment in families with parents with ID and improve long-term health and social
opportunities for children. The overall objective in this application is to determine the degree to which Project
IMPACT, a family preservation program designed to meet the specific needs of parents with ID who have
child welfare involvement, is effective at reducing foster care placement. The central hypothesis is that Project
IMPACT will be effective at reducing foster care placement for participating families. The hypothesis has been
formulated based upon preliminary studies completed by the investigators in 2019. The rationale for this
project is that evidence is needed to determine the degree to which this innovative program is effective at
preventing child maltreatment and, subsequently, foster care placement. If it is determined that this program
is efficacious, it will be the first effective program developed and implemented in the U.S. designed for this
high-risk population. Expected outcomes include findings that can be used to support program replication,
additional rigorous study, and submissions to evidence-based clearinghouses including those supported by
the Family First Prevention Services Act. Aim 1 will assess the degree to which participation in Project
IMPACT is effective at reducing foster care placement for families with child welfare involvement in which a
parent has ID compared to families in which a parent has ID and are engaged in a non-specialized family
preservation program. Aim 2 will assess the degree to which participation in Project IMPACT is effective at
reducing foster care placement for families with child welfare involvement in which a parent has ID compared
to families in which a parent has ID and are not engaged in any family preservation program. This research
will use propensity score analysis to draw causal inference between program participation and foster care
placement in the year after termination from the program. Data for the treated group will come from Project
IMPACT clinical data records for clients beginning service between 2006 and 2018; the matched untreated
samples will be drawn from the restricted National Child Abuse and Neglect Data Systems Child Files in the
same years. The proposed study is innovative because it will be the first to determine the efficacy of a
program designed for parents with ID with child welfare involvement. The proposed project is significant
because children of parents with ID are at particularly high-risk for disruptive child welfare trajectories and
outcomes.

Public health relevance
PROJECT NARRATIVE The proposed research aims to understand how Project IMPACT, a family preservation program designed for child welfare-involved families in which a parent has an intellectual disability (ID), is effective at reducing foster care placement, an indicator of serious child maltreatment. This is a public health priority because maltreated children are at high-risk for long-term negative health outcomes, yet there is a dearth of research examining effective interventions for preventing maltreatment in children of parents with ID despite indicators that they are a sizeable portion of the U.S. child welfare population. This project is aligned with the NICHD Strategic Plan 2020 Research Theme 4 focused on improving child and adolescent health and is consistent with the NICHD Pediatric Trauma and Critical Illness Branch’s priority focused on the prevention and treatment of traumatic injuries in children.